Ultradian to circadian transcriptome re-wiring underlies liver aging

Project Summary/Abstract
In addition to the circadian rhythms (~24h oscillation), ultradian rhythms (with period smaller than 24h) also exist,
among which 12h rhythms were prevalently found in multiple species ranging from circatidal marine animals, to
nematode C. elegans and mammals like mouse, baboon and even humans. Our group recently discovered a
mammalian 12h-clock that is evolutionarily conserved, cell-autonomous and established independently from the
circadian clock but dependent on the unfolded protein response transcription factor XBP1s. Liver-specific
deletion of XBP1s globally impairs the murine 12h transcriptome, but not circadian rhythms in vivo. XBP1s-
dependent hepatic 12h transcriptome preferentially peaks at dawn and dusk, and is remarkably enriched in
pathways regulating innate immune functions and endoplasmic reticulum (ER) and the Golgi apparatus
homeostasis, including translation regulation, protein processing and sorting in ER and Golgi, protein quality
control and sphingolipid and glycerolipid metabolism. These pathways are often dysregulated during aging and
aging-related diseases. While it has been recently established that the 24h circadian rhythms undergo prevalent
reprogramming during aging, whether the 12h-clock dysregulation is also causally linked to aging and/or aging-
related diseases remains ill defined. Very intriguingly, preliminary data revealed a very robust global
reprogramming of 12h-cycling transcriptome to 24h circadian rhythms during aging in mouse liver, which is
further associated with a conversion of 12h hepatic XBP1s oscillation to 24h circadian oscillation. Based upon
these findings, we hypothesize that 12h-to-24h (circadian) reprogramming can accelerate liver aging. We will
generate mouse models of hepatic 12h-to-24h reprogramming. Extensive phenotyping experiments will be
performed to determine if genetically-induced 12h-to-24h reprogramming is sufficient to drive hepatic aging in
mice. We will further perform temporal RNA-Seq and hepatic secretome profiling to identify the molecular
mechanism underlying this reprogramming. This work will therefore establish 12h-clock dysregulation as a novel
hallmark of aging and suggest that new therapeutics aimed at preventing this 12h-to-24h reprogramming could
be effective at improving health span in humans.

Public health relevance
Project Narrative Circadian rhythm is a fundamental process that synchronizes behavioral cues with metabolic homeostasis and disruption of diurnal cycles due to jet-lag or shift work results in severe physiological consequences including advanced aging, metabolic syndrome, and cancer. Interestingly, in addition to the 24h circadian rhythm, ultradian rhythms (rhythms with period smaller than 24h) such as 12h period of biological rhythms are also found from ancient marine species to mouse and humans. The purpose of this research is to help answer the basic questions of how the 12h rhythm is established at the molecular level, how the disruption of it will lead to diseases and how we can exploit the 12h rhythm to prevent and treat diseases.